A digital mindfulness-informed parenting intervention for high-risk divorced families

PROJECT SUMMARY/ABSTRACT
This K01 will provide the Principal Investigator (PI), Dr. Na Zhang, with training and research experiences that
will support and prepare her to become an interdisciplinary independent researcher who optimizes and
evaluates digital parenting interventions by leveraging mindfulness techniques to prevent parent and child
mental health problems in high-risk families such as divorced families. Divorce is highly prevalent, and it
confers significant risks of mental health problems to both children and parents. The training activities will
provide Dr. Zhang the necessary research experience and skills to achieve her long-term career goals,
including clinical training, intervention development, RCTs, and expertise in studying the proposed intervention
targets, parental cognitive control and emotion socialization. These training goals will be accomplished by
directed readings, coursework, workshops, seminars/webinars, practicum, hands-on training, collaborative
papers, conference activities, and applied research experiences. The proposed research is aimed to meet the
needs of distressed divorced parents to ensure that they can benefit from evidence-based practices, by adding
mindfulness training (MT) to the electronic New Beginnings Program/eNBP. The proposed research has three
Aims: 1) To elucidate the perspectives of end users and stakeholders; 2) To design and refine digital
mindfulness training modules and engagement strategies via user testing; and 3) To determine feasibility,
acceptability, and preliminary efficacy of the MT+eNBP. Co-primary mentorship will be provided by Dr.
Sharlene Wolchik (Arizona State University; clinical psychologist, expert in parenting interventions for high-risk
families, and co-developer of the eNBP) and Dr. Kim Gans (University of Connecticut; expert in mixed method
formative research for intervention development and in conducting RCTs). Collaborators include Dr. Judson
Brewer (Brown University; expert in digital mindfulness-based interventions), Dr. Larissa Duncan (University of
Wisconsin - Madison; expert in mindfulness-enhanced parenting interventions and mindful parenting), Dr.
Aaron Lyon (University of Washington; expert in user-centered design), Dr. Kirby Deater-Deckard (University of
Massachusetts - Amherst; expert in parental self-regulation, executive functions, and parenting), and Lynn
Katz (University of Washington; expert in parental meta-emotion philosophy and emotion coaching). The
proposed K01 training and research activities will be completed at the University of Connecticut, Department of
Human Development and Family Sciences and the Institute for Collaboration on Health, Intervention, and
Policy (InCHIP).

Public health relevance
Project Narrative Elevated mental health problems have been documented in children of divorced families – over 8.1 million in the US – and in their parents. While behavioral parent training interventions, including digital interventions, have demonstrated success to reduce children’s mental health problems, they have shown weaker effects in divorced parents with elevated psychological distress, and digital fully self-administered interventions have shown no effects to reduce the distress of divorced parents. By developing digital mindfulness training components and adding them to an existing evidence-based parenting intervention, as a combined, web- based, self-administered intervention, this project has great potential to maximize its reach and impact, reducing mental health problems in high-risk divorced families.